Mechanical Regulation of Cell Fate and Multi-Scale Function in the Developing Meniscus

Abstract
The meniscus plays a vital role in knee function, but injury is common and healing is limited in adults.
Development of effective regenerative solutions is challenged by our limited understanding of the cellular
mechanisms that regulate meniscus formation, maturation, and maintenance. In the previous funding cycle, we
queried the origins of cell fate and biosynthetic function in the developing meniscus. We found that the
embryonic-to-early postnatal growth period is the most active time frame of meniscus cell specification,
patterning, and regional specialization. We also demonstrated a central role of external mechanical loading and
internal cell mechanosensing in regulating meniscus patterning, growth and matrix organization during this early
developmental phase. Despite these findings, the timing and mechano-epigenetic mechanisms controlling the
early development of meniscus remain unresolved. To address this, in this renewal, we aim to elucidate the roles
of cellular force generation and mechanosensing machinery in the formation of the meniscus during early
development, as well as its maintenance in the adult. Our central hypothesis is that cell generated tension is
essential for meniscus cell inner-to-outer specification and maintenance across the meniscus lifecycle. To test
this hypothesis, we will induce timed ablation of cellular force generating machinery, the non-muscle myosin
(NMII) genes Myh9 and Myh10 (Myh9/10) in meniscus progenitors at key developmental time points, as well as
in the adult meniscus. We will test if this ablation results in aberrant patterning and matrix formation during early
development and if it results in loss of cell phenotype and matrix degeneration in adults. Specifically, Aim 1 will
determine the role of acto-myosin contractility in the specification and development of the embryonic meniscus.
We will test if early ablation of Myh9/10 in the murine embryonic meniscus results in aberrant patterning, and if
later ablation leads to insufficient matrix elaboration and impaired maturation. Aim 2 will establish the mechano-
epigenetic basis of contractility-mediated regional specification within the embryonic meniscus. Single cell RNA-
seq will be applied to evaluate phenotypic heterogeneity at key time points. We will also apply ATAC-seq to
determine if ablation of contractility and/or Myh9/10 decreases the accessibility at fibrous matrix genomic loci
and increases the accessibility at chondrogenic/remodeling loci in porcine meniscus progenitors cultured in vitro.
Aim 3 will determine if loss of cellular force generation and mechanosensing machinery in the adult instigates
meniscus degeneration. We will test the effect of Myh9/10 ablation in adult mice by evaluating meniscus cell
mechanosensing, fate, matrix production and mechanical properties, and assess how adult porcine and human
meniscus cells shift their phenotype upon the loss of tension in vitro. We expect the outcomes to generate novel
data defining the mechanobiologic basis of cell fate determination, matrix specialization in the developing
meniscus, and postnatal maintenance, providing new insight to direct regenerative strategies in adults.

Public health relevance
Project Narrative The meniscus plays a vital role in knee function and is prone to injury, but the cellular mechanisms regulating its development, maturation and maintenance are poorly understood. This project seeks to fill this knowledge gap by elucidating the role of cellular force generation and mechanosensing in regulating embryonic meniscus patterning, cell fate determination and matrix specialization during embryonic-to-early postnatal growth, and in maintaining cell phenotype in the adult meniscus. Results will establish the mechanobiological basis that regulates the meniscus development and homeostasis, providing new insight to direct regenerative strategies.